Translational Core for Therapeutic and Diagnostic Development

PROJECT SUMMARY: TRANSLATIONAL CORE FOR THERAPEUTIC AND DIAGNOSTIC DEVELOPMENT
The Translational Core for Therapeutic and Diagnostic Development (TCTDD) will enhance the research
programs of a growing number of R01 funded investigators engaged in basic science research by providing
powerful new data science and high throughput data analysis support. Currently, NEI R01 grants supported by
this P30 grant are engaged in basic biomedical research (T0 research) with explicitly stated goals of translation
of research findings for new methods of diagnosis, treatment, and prevention of eye diseases (T1 research). The
TCTDD core will provide Data Science and Artificial Intelligence (AI) services for pre-processing, analysis and
visualization of basic research data (molecular, cellular and imaging) to provide deeper mechanistic insights and
synergistic opportunities for moving towards translational research (Aim 1). The TCTDD core will also provide
technology-driven, automated services to bolster the research throughput for generating high quality, rigorous
research data which will expand the breadth and depth of basic science research while accelerating related
translational research (Aim 2). The long-term goal is to accelerate discoveries that easily transit from bench-to-
bedside.